Department of Energy: Oak Ridge Institute for Science and Education Program

This Interagency Agreement sets forth the terms of the services and technical assistance to be provided by the Oak Ridge Institute for Science and Education (ORISE), NIH Research Participation Programs. Under this agreement, ORISE and the NCI shall work to provide extensive analysis and interpretation of routine/descriptive cancer statistics, projections of future cancer burden and estimations of attributable causes of cancer. This agreement allows the NCI to work with ORISE to offer for a high-level sense familiarity with standard techniques and novel bio statistical models, namely the age-period-cohort models. The partnership afforded by the NCI and ORISE offers the unique ability to apply these models to cancer incidence and mortality as well as to forecast the future burden of cancer.